Technology-Supported Treatment of Sleep Apnea in Prediabetes

PROJECT SUMMARY
Intensive lifestyle interventions (diet and exercise) are the mainstay of treatment in prediabetes. Despite their
efficacy, diabetes incidence is rising, and thus there is a critical need for additional strategies to prevent diabetes
and to reduce its cardiovascular complications. Sleep apnea is a treatable disorder that has been strongly
associated with cardiometabolic disease. Continuous positive airway pressure (CPAP) is the recommended
treatment for those who are diagnosed with sleep apnea. However, about 80% of patients who have sleep apnea
remain undiagnosed, and thus not receive CPAP treatment. To date, not a single clinical trial investigating the
effects of lifestyle interventions on cardiometabolic risk in prediabetes assessed for sleep apnea or included an
intervention to treat sleep apnea. Despite high prevalence of sleep apnea in prediabetes, the vast majority of
patients are not diagnosed due to lack of high level evidence to indicate that treatment specifically improves
diabetes and cardiovascular outcomes, which are the primary treatment objectives of specialists caring for this
high-risk population. Moreover, due to insufficient evidence from rigorous and well-powered randomized
controlled trials, the U.S. Preventive Health Services Task Force recommended against general screening for
sleep apnea. Notably, not a single randomized controlled CPAP trial assessing cardiometabolic outcomes
utilized a technology-supported intervention to promote adherence, a key limitation in prior studies. Our proposed
randomized clinical trial will fill these critical knowledge gaps and address a focused, novel and clinically relevant
question. We will determine, for the first time, whether adding CPAP treatment to a lifestyle intervention improves
cardiometabolic outcomes beyond that achieved with lifestyle alone (i.e. current standard of care) in prediabetes.
Overweight and obese adults who have prediabetes and sleep apnea will be randomly assigned to lifestyle alone
or lifestyle plus CPAP. We will obtain the same metabolic and cardiovascular assessments at baseline and after
6-months of intervention. Our specific aims are to test the hypothesis that a combined intervention (lifestyle plus
CPAP) will lead to greater improvements in glucose levels, insulin sensitivity and beta cell function (Aim 1), and
blood pressure and lipid profile (Aim2), as compared to lifestyle alone. To maximize intervention success and
minimize subject burden, we propose a highly efficient, cost effective technology-supported approach for lifestyle
intervention and CPAP treatment, which will allow real-time, objective monitoring of individuals in their habitual
environment and delivering timely feedback to attain goals. To date, no prior study has implemented such a
technology-supported intervention in people with prediabetes and sleep apnea. An added benefit of CPAP on
cardiometabolic outcomes will strongly support routine screening for and treatment of sleep apnea in prediabetes
and will encourage those prescribing CPAP to routinely implement intensive lifestyle modifications as part of
treatment package for sleep apnea. Our trial will address a major gap in randomized clinical trials on the impact
of sleep apnea treatment on glucose metabolism, and thus inform evidence-based clinical decision making.

Public health relevance
Despite the efficacy of intensive lifestyle interventions in prediabetes, the incidence of diabetes is rising, and thus there is a critical need for additional strategies to prevent diabetes and to reduce its cardiovascular complications in this high-risk population. Sleep apnea is a highly common condition in prediabetes, but it has been mostly ignored and undertreated in current practice. The proposed study will be the first to assess whether adding CPAP treatment to a lifestyle intervention improves cardiometabolic outcomes beyond that achieved with lifestyle alone (i.e. current standard of care) in high-risk individuals with prediabetes.